ABNORMALITIES IN GLUCOSE HOMEOSTASIS IN INFANTS AND CHILDREN

This protocol is designed to determine the pathophysiology, treatment and natural history of hypoglycemic disorders. Stable isotope studies of fuel metabolism are included.